Investigation of in vivo efficacy of G-protein biased mu opioid receptor agonists.

PROJECT SUMMARY
Typical mu-opioid receptor (MOR) agonists (e.g., oxycodone, fentanyl) are efficacious analgesics for the
treatment of moderate to severe pain. However, the therapeutic window of typical MOR agonists for pain
management is limited by their unwanted side effects such as respiratory depression and abuse liability. The
limitations of typical MOR agonists have prompted the development of novel MOR agonists (e.g., PZM-21, SR-
17018) with more favorable safety profiles. However, the mechanism by which these novel agonists produce
their more desirable behavioral effects is still unknown. One body of evidence indicates that the compounds
exhibit improved side-effect profiles due to G-protein signaling bias. However, more recent work has
challenged this position with evidence indicating that these novel agonists are merely partial agonists at the
MOR. Thus, the results from in vitro investigations into mechanisms are conflicting and in vivo studies are
lacking. The purpose of this proposal is to investigate a series of G-protein biased MOR agonists in preclinical
models of therapeutic and side effects, and under experimental conditions designed to differentiate typical from
partial MOR agonists. Under these conditions, typical MOR agonists produce maximal magnitude of effects,
and partial MOR agonists produce sub-maximal magnitude of effects. Specifically, Aim 1 will measure the
magnitude of analgesia produced by novel MOR agonists in comparison to typical and partial MOR agonists
under different levels of thermal nociceptive stimulation in a hot-plate assay. Aim 2 will measure the magnitude
of respiratory depression produced by novel MOR agonists, in comparison to typical and partial MOR agonists
in a whole-body plethysmography assay. Aim 3 will compare the maximum breakpoint (indicator of abuse
liability) mediated by typical, partial, and novel MOR agonists in a self-administration assay under increasing
levels of operant challenge provided by a progressive-ratio schedule of reinforcement. Based on the profile of
behavioral effects engendered by the novel MOR agonists, we will be able to determine which in vitro position
is most closely recapitulated in vivo. Ultimately, our findings from these three aims will inform the development
of opioid-based therapeutics with more favorable safety profiles and wider therapeutic windows. To accomplish
these aims, the training plan was described in this proposal, and, it will be carried out at the Jackson campus
of the University of Mississippi Medical Center. The applicant will be receiving scientific training and
professional development from the sponsor, the sponsor's collaborators, the Program In Neuroscience, and
the School of Graduate Studies in the Health Sciences.

Public health relevance
PROJECT NARRATIVE The increase in overdose-related deaths associated with the misuse of clinical opioids has prompted synthesis efforts geared towards designing safer opioids. Novel atypical opioid agonists have been developed that appear to have a favorable profile of behavioral effects, producing full analgesia with fewer unwanted side effects (e.g., respiratory depression, abuse liability); however, the mechanisms underlying the improved profile are not known. Our studies will determine the extent to which the desirable profiles of these agonists are due to low intrinsic efficacy at mu-opioid receptors or to preferential activation of one of the mu-opioid receptor’s signaling pathways.